Epstein-Barr Virus positive post-transplant lymphoproliferative disorders: identifying viral and host variables to predict risk and develop novel management strategies

PROJECT SUMMARY/ABSTRACT
Post-transplant lymphoproliferative disorder (PTLD) is the second most common cancer and a leading cause of
death in solid-organ transplant recipients. Most PTLD cases are associated with Epstein-Barr virus (EBV), a
highly prevalent oncogenic virus. Our limited understanding of PTLD risk, inadequate monitoring strategies, and
lack of therapeutic options undermine our ability to address PTLD-associated morbidity and mortality. While we
have identified a limited number of PTLD risk factors, these factors are insufficient to predict which patients are
at greatest risk. Understanding the specific factors driving PTLD risk and development remains an unmet need
required to monitor high risk patients and prevent PTLD development. We hypothesize that disruptions in the
balance between host T follicular helper, T regulatory (Treg), cytotoxic T lymphocytes and T follicular cytotoxic
lymphocyte subsets, and their associated cytokines, IFN-γ and TGF-β, create a permissive environment for EBV
lytic reactivation and B-cell transformation and that these disruptions can be leveraged as predictive biomarkers
and therapeutic targets for patients with PTLD. To test this, human samples and a chimeric human-mouse model
of EBV driven lymphoproliferative disorder (hu-PBL-SCID) will be utilized. Blood samples from patients who
developed PTLD and samples from patients who failed to develop PTLD will be analyzed with a custom spectral
flow cytometry panel allowing for the investigation of the indicated immune cell subsets and their relationship to
PTLD development. Additionally, a novel and rapid EBV DNA methylation assay will be used to characterize the
EBV epigenetic profile in cell-free DNA in the plasma of patients with PTLD and those without PTLD. This assay
can distinguish lytic (infectious) from various latent viral states and offers valuable diagnostic information to
identify PTLD early. Methylation profiles from plasma and, when available, PTLD tumor biopsies, will be
compared to clinical state and contribute toward biomarker development. All epigenetic and immunophenotypic
data will be correlated with clinical outcomes to identify biomarkers that predict PTLD risk. Finally, based on
preliminary data showing the importance of Tregs in preclinical and clinical studies of EBV driven
lymphoproliferative disease, the hu-PBL-SCID model will be treated with a novel monoclonal antibody able to
reduce Treg quantity and levels of the Treg associated cytokine, TGF-β. Spectral flow cytometry and methylation
studies will be performed on murine samples and survival will be analyzed to explore if treatment is able to
diminish PTLD driving subsets and prevent disease. This project holds potential to shed light on PTLD
pathogenesis and identify risk factors and therapeutic targets.

Public health relevance
NARRATIVE Epstein-Barr virus associated post-transplant lymphoproliferative disorder (PTLD) is a leading cause of death in solid organ transplant recipients and the lack of known risk factors, standard monitoring strategies, and treatment options has prevented us from reducing PTLD associated morbidity and mortality. This proposal aims to address these key deficiencies by studying how host immune and viral epigenetic disruptions contribute to PTLD development. These disruptions can then be leveraged to improve risk stratification in organ allocation, advance PTLD monitoring strategies, and identify novel targets for PTLD prevention and treatment, ultimately leading to improved overall outcomes for solid organ transplant recipients.